IRF3 activation promotes fibrotic liver injury in alcohol-associated-liver disease

Project Summary/ Abstract
Deaths from alcohol-related liver disease (ALD) are increasing due to a surge in underlying liver disease and
increased alcohol consumption. ALD is a term used to describe a spectrum of diseases that range in severity.
Patients with advanced disease, including fibrosis have few treatment options. Fibrosis is a disease stage
indicative of transition from benign to progressive disease. Therefore, there is a clinical urgency to understand
the molecular mechanism triggering fibrosis in patients with ALD to aid in the development of effective treatments
strategies to curb ALD progression and improve survival. This requires an understanding of immune cell
mediators responsible for modulating the dynamic interplay between liver injury and repair. Interferon regulatory
factor 3 (IRF3) is a transcription factor that induces antiviral genes and is implicated in the progression of ALD.
IRF3 also has non-transcriptional function involving a pro-apoptotic pathway mediated by the dsRNA binding
protein (DRBP) RIG-I and IRF3 which can interact with IKKb to prevent NFkB transcription of inflammatory
cytokines. Ethanol-induced stress in hepatocytes results in increased generation of dsRNA, triggering
downstream inflammatory cytokine production. dsRNA originates from viral replication or host-derived sources
and it functions as a damage associated molecular pattern (DAMP) to signal injury (traditionally from viral
infection). Currently, the most investigated source of dsRNA accumulation in the absence of viral infection
originates from the mitochondria and is associated with aberrant dsRNA degradation pathways. In the context
of ALD, we predicted that dsRNA contributes to an exaggerated immune response worsening living injury and
fibrosis. This may be mediated via dsRNA-induced IRF3 activation. Our lab demonstrated that Irf3-/- mice were
protected from ethanol-induced liver injury, while mice expressing only non-transcriptional function of IRF3 were
not protected. This non-transcriptional effect of Irf3 was driven by IRF3-mediated apoptosis of specific
populations of infiltrating monocytes that resulted in worsened hepatic inflammation and contributed to ethanol-
induced injury in mice. Preliminary data from this proposal demonstrates that in a chronic CCl4 fibrosis injury
model, Irf3-/- mice have less fibrotic injury and increased infiltration of neutrophils, an innate immune cell
population recently implicated in protection from injury. Therefore, since IRF3 modulates monocyte phenotype
and increases neutrophil infiltration and dsRNA can trigger immune responses in ALD via IRF3, we hypothesize
that ethanol increases dsRNA-induced IRF3 activation contributing to neutrophil infiltration and increased fibrotic
liver injury associated with ALD. In this proposal, we will determine how IRF3 activation in vivo increases liver
injury in an alcohol-accelerated fibrosis model and characterize in vivo knockout models dsRNA sensing
response to ethanol. We will also determine the role of IRF3 in modulating neutrophil infiltration and phenotype
in an alcohol-accelerated fibrosis model. Completion of these studies will contribute towards a better
understanding of the crosstalk between the innate immune system and ALD-associated fibrosis.

Public health relevance
Project Narrative Alcohol-associated liver disease (ALD) describes a spectrum of disease classified by chronic heavy alcohol consumption that eventually results in the development of hepatic fibrosis, a disease state that marks transition to severe disease and has no effective treatments. More effective drug development to treat fibrosis requires an understanding of immune cell mediators responsible for modulating the dynamic interplay between liver injury and repair. These studies will determine the role of dsRNA-induced IRF3 activation (a viral innate immune response mechanism) in ALD fibrotic liver injury, including its role in modulating innate immune cell populations.